Administrative Core

PROJECT SUMMARY (ADMINISTRATIVE CORE)
The mission of the University of Southern California (USC) CLIMAte-Related Exposures, Adaptation, and Health
Equity (CLIMA) Center is to develop the scientific knowledge base, investigator teams, and community
engagement needed to identify mitigation and adaptation strategies to reduce the burden of disease and
disability from climate change and increase individual to community climate resilience. The CLIMA Administrative
Core (AC) will play a critically important role in establishing and maintaining an integrative infrastructure for
CLIMA Cores, Research Projects, and investigators, and building new research infrastructure and data pipelines
for climate and health research in partnership with USC and other climate science partner institutions across
southern California. The AC will function as the primary supporter of ensuring all scientific and programmatic
functions of the CLIMA Center are coordinated and integrated across all components and all resources are
responsibly and efficiently managed. The AC will support CLIMA through the following aims: (1) provide an
integrated infrastructure for all scientific and administrative CLIMA resources and establish an intentional vision
and culture for collaborative, transdisciplinary team science; (2) cultivate Youth Climate Action Fellows and
junior, mid-career, and senior investigators' careers and research programs in Climate Change, Adaptation, and
Health (CCAH) to advance CLIMA objectives; (3) promote and organize interactions with the larger CCAH
research and policy community; and (4) monitor and evaluate the productivity and success of CLIMA programs
and activities and provide fiscal, resource, and reporting oversight and management.